EXPERIMENTAL MODEL OF H PYLORI INFECTION IN RHESUS MACAQUES

Significance We have continued our studies of Helicobactor pylori infection in rhesus macaques using the urea breath test (the application of which we have adapted to non-human primates), gastric biopsy techniques (including culture, histology, and PCR), and drug treatment of infected animals. Objectives Our objectives continue to revolve around a better understanding of the natural history of infection with H pylori in order to facilitate treatment and prevention of this disease in humans where it can cause gastric ulcers and neoplasia. Our most significant recent accomplishments include the development of a sensitive and specific serologic assay for H pylori in rhesus macaques, and the finding that the urea breath test, a test receiving increasing application in humans for the diagnosis of H pylori infection, is not sensitive for the detection of early (experimental) infection. Future Directions Future goals include identification of a human isolate of H pylori which will infect rhesus macaques in order to improve our primate model and elucidation of the mechanism of transfer of this infection among animals. KEYWORDS Helicobactor pylori, immunization